Integrative Health Sciences Facility Core

The Integrated Health Sciences Facility Core (IHSFC) facilitates multi-directional translational research between
mechanistic, toxicological, clinical, and population-based studies to inform the scientific community, public health
policy, and education. The IHSFC furthers the mission of the Southwest Environmental Health Sciences Center
(SWEHSC) with a focus on the environmental exposures affecting human health that are unique to the arid
Southwest environment. The mission of the IHSFC stems from the three SWEHSC research themes:
environmental exposures to people in the Southwest, environmental lung disease, and adaptive responses to
environmental stressors, which span a number of environmental exposures including organic solvents, metals
and metalloids, airborne particulate matter, and UV light exposure. To foster integrated environmental health
research, the IHSFC is organized around three operational components. The Implementation Resource for
Translational and Human Exposure Research provides strategic advice and resource support to SWEHSC
investigators in sampling Southwest human populations and their living environment, communicating research
findings with key stakeholders, and in helping investigators navigate translational research barriers. The Data
Science Resource provides statistics, bioinformatics, database development and integration, and highperformance
computing support and resources to investigators within a model of project partnership. The
Inhalation Exposure Resource provides a vital new core facility to conduct inhalation exposure experiments in
rodent and cellular models. By combining these three resource areas, the IHSFC provides integrated services
and expertise in environmental exposure measurement and modeling, statistical modeling of the relationship
between exposure and health outcomes, and mimicking real world exposures in experimental models of disease
to understand their mechanistic underpinnings. IHSFC scientists work with investigators from all three SWEHSC
research focus groups (RFGs) and Pilot Projects, serve as mentors for Career Development beneficiaries, and
work with the Cellular Imaging and Omics Facility Cores to ensure consistent, professional statistics and
bioinformatics study design, data management, and connectivity. Finally, the IHSFC collaborates extensively
with the Community Engagement Core (CEC) to leverage established relationships with community
stakeholders, identify exposures of concern to communities, assess environmental health literacy, and identify
effective strategies for communicating research results and environmental risk to the people of Arizona and the
Southwest.